COMPARISON OF THREE ASPIRIN FORMULATIONS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. To identify any pharmacokinetic differences in three different aspirin formulations, all of which are currently employed in the treatment of Acute Coronary Syndrome (ACS), which includes myocardial infarction or heart attack.